Center for Restoration of Nervous System Function

Chronic pain and spasticity are major unmet needs within the VA. Since our discovery of Nav1.7 as a “master
switch” for pain in humans, the biopharma industry has invested more than $1 billion in development of Nav1.7
blockers. That work is continuing with the development of 2nd-generation blockers that build on our initial efforts
(Cao et al., 2016) and the targeting of Nav1.8 which functions in concert with Nav1.7. We are committed to
more effective, non-addictive treatments for pain and spasticity in Veterans and are taking a “multiple shots on
goal approach” through the following novel efforts.
Research Program I: Pain Pharmacogenomics. A. Pain Resilience—Why do some people experience
severe pain after injury, while others feel little or no pain? We have begun to use our innovative platform of
patient-specific stem cells to identify genes that confer resilience to pain. Thus far we have identified Kv7.2 and
Kv7.3 channels as strong modulators of pain and are analyzing KCNK18. These are potentially druggable
targets. Going forward we will analyze the effect of pharmacological agents on these protective channels as a
prelude to clinical studies. B. Limb Amputation & Phantom Limb Pain in Veterans—Building upon our
success in identifying genetic risk factors in patients with painful neuropathy, trigeminal neuralgia and ocular
pain, we now plan to identify genetic risk factors in Veterans with limb amputation and phantom limb pain
(Hannon Act Sect. 305) as a prelude to larger-scale studies in Veterans that capitalize on the MVP database.
Research Program II: Accelerating Toward Improved Pain Pharmacotherapy. A. Chemotherapy-
Induced Pain—We have demonstrated that chemotherapy affects sensory neurons in a drug-dependent
manner and are building a unique collection of animal models to advance this research, which has important
implications for Veterans with CIPN. We are also evaluating cannabinoids as a therapy for CIPN. B.
Osteoarthritis—We are advancing an entirely new approach to treatment of osteoarthritis (OA), an unmet
need in Veterans, having demonstrated that Nav1.7 is upregulated within human OA chondrocytes and
contributes to disease progression. We are now elucidating the actions of Nav1.7 in OA and assessing Nav
blockers in animal models and human tissue to attenuate pain and slow disease progression in OA. C. Novel
Discovery Platforms—We are developing innovative stem cell technology platforms, powerful methods to
visualize transport of single ion channels, and high-throughput assays for drug screening.
Research Program III: New Treatments for Spasticity. We have uncovered ventral horn dendritic spine
dysgenesis as a strong contributor to spasticity following SCI, validated Rac1-Pak1 pathway as a novel target,
and are evaluating the repurposing of FDA-approved Romidepsin to inform human clinical trials (provisional
patent filed through VA TTS). We are developing powerful new methods—intravital visualization of dendritic
spines via spinal cord window implants, high-resolution two-photon microscopy, and virtual reality integration,
to utilize spine dysgenesis as a biomarker as we progress our animal studies toward human clinical trials.
Research Program IV: Targeting Nav1.7 through RNA Editing. Advancing in a multi-pronged approach to
feed the translational pipeline to novel, effective non-addictive treatments for pain, we are developing RNA
editing as a novel approach to target Nav1.7, which remains one of the best validated targets for chronic pain.
Research Program V: Targeting Nav1.8 with Repurposed Drugs. Advancing in a multi-pronged approach
to feed the translational pipeline to novel, effective non-addictive treatments for pain, we are evaluating the
repurposing of two drugs, Dexpramipexole (DEX) and Ambroxol. Ambroxol is known to block Nav1.8, which
works with Nav1.7 to control the firing of pain-signaling neurons. We have shown that DEX blocks Nav1.8 and
reduces pain in several animal models. We will now assess DEX and Ambroxol in a head-to-head comparison
as a prelude to a clinical study using one or the other for the treatment of chronic pain.

Public health relevance
Chronic pain is more prevalent and of greater intensity in Veterans than in the general population (VA Research on Pain Management Factsheet 2020). According to CDC, an estimated 25% (58 million) of U.S. adults have chronic pain. Chronic pain is highly prevalent in Veterans with nerve and spinal cord injury, traumatic limb amputation, burn injury, cancer, osteoarthritis, and peripheral neuropathy. There are also over 27,000 Veterans with SCI and related disorders including MS, who suffer from spasticity. Current treatments for chronic pain and spasticity are inadequate; they carry dose-limiting side effects and exert CNS side effects including the risk of abuse and addiction. Our research is aimed at developing better treatments for chronic pain and spasticity to substantially improve rehabilitation and quality of life of Veterans.